Metal Chelate Conjugated Monoclonal Antibodies for Tumor Diagnosis and Therapy

Tumor associated monoclonal antibodies (mAbs) are therapeutic agents when used as selective vectors of cytotoxic agents towards malignant tissues. This hypothesis is tested in animal model systems with mAbs directed toward antigens associated with human disease. The cytocidal agents employed are particle emitting radionuclides. The relative efficacy is evaluated in validated murine tumor xenograft models. The radionuclides chosen focus on appropriate alpha emitters and beta emitters. The research has focused on Pb-212, a beta-emitter and subsequent alpha particle source, in parallel with alpha emitters, At-211 and Th-227 for true comparative efficacy studies of Bi-213, Pb-212, At-211, and Th-227. However, effectively at this time there are 5-6 completed pre-clinical studies remaining to published before this project closes with the retirement of Dr. Brechbiel. These studies investigate the use of mAb fragments of panitumumab as a targeting delivery vector along with investigations into the impact on efficacy on choice of administration route. A significant hi-lite from the studies performed by the Chemistry Section is within a recent publication in Trans. Oncol. That demonstrates what may be the strongest survival and curative results to date using 212Pb targeted to the EGFR by panitumumab to treat a highly aggressive disseminated ip disease model of colorectal or ovarian cancer. The publication reports a median survival of greater than 280 days, but that is because there was an 80% survival of the treated animals vs. the controls surviving no more than 21 days. In fact, this group of animals survived in block over 300 days. The combination therapy that was investigated that generate this result was with topotecan. The key point here was the dosing schedule; the topotecan was given 24 hours prior to and then again 24 hours post-administration of the 212Pb-panitumumab. Use of just a single dose of topotecan either prior to or post failed to provide meaningful therapeutic efficacy. The significance of these studies, beyond just the creation of a curative therapy in this animal tumor model is quite simple - this also demonstrates the need for the execution of rather complex animal tumor model based studies top define the proper integration of the components of combination therapies. This requirement has been demonstrated repeatedly; in vitro experiments cannot predict these results and this must be performed empirically. The use of topotecan had been largely abandoned by the Chemistry Section as component of combination therapy due to the unimpressive results that were generated using single doses of the drug combined with 212Pb targeted by an antibody. However, the adoption of a dual dose regimen, completely unpredicted, demonstrated far superior efficacy. To this end, the Chemistry Section has again performed one of the very few new targeted radiation therapy chemotherapy combination studies to demonstrate the potential of a very potent therapy that would also have very real clinical and translational therapeutic potential.